Behavioral, dietary and pharmacological modalities of cardioprotection

The broad objective of this program is to perform preclinical experimentation on rodent models of myocardial ischemia to test the effect of dietary manipulations prior to ischemic event to increase the tolerance of the cardiac tissue to ischemic damage.[unreadable] [unreadable] I. Intermittent Fasting (IF), i.e., the feeding regimen when ad lib food is available only every other day, had been reported to increase the life span and to reduces the incidence of age-associated diseases including cancer, diabetes and kidney disease. Neuroprotective effects of IF against ischemic injury of the brain have also been reported. We investigated the cardioprotective effect of IF in rats using the model of experimental myocardial infarction induced by a permanent coronary ligation. After three months of IF or regular, daily, feeding ad libitum (AF), 5-mo old rats were subjected to coronary ligation or sham operation. A subset of rats was sacrificed 24 hours later to measure the size of myocardial infarction (MI) and the extent of apoptosis. The remainder of the animals were continued for 10 weeks on the same food regimen, during which time the progression of left ventricular (LV) remodeling was assessed by serial echocardiography. After ten weeks LV function was measured by pressure-volume loops analyses, and hearts were evaluated histologically. We showed that 24 hrs following coronary ligation the ischemic area of myocardium, i.e., the area at risk (AAR), was similar in both groups, but in IF rats MI size, expressed as a percent of AAR, was more than 2-fold smaller, apoptosis in the AAR was reduced by more than 4-fold, and the inflammatory response was significantly reduced. At 10-wks, late LV remodeling and MI expansion occurred in AF rats but not in IF rats, and LV pump function and arterio-ventricular coupling were superior in IF vs AF rats. The myocyte hypertrophy in areas remote from the MI was also absent in IF rats. The results indicate that Intermittent Food Deprivation protects the heart from ischemic injury in part, at least, via an enhanced anti-apoptotic mechanism. In the last experiments we demonstrated that IF improves glycemic control and results in the increase of the levels of circulating adiponectin. Because recent studies have shown that adiponectin can protect the heart against ischemic injury, adiponectin may mediate, at least in part, the cardioprotective effect of IF. [unreadable] II. Blueberry supplement. Reactive oxygen species (ROS) play a major role in ischemia-related myocardial injury. However, the attempts to use synthetic antioxidants to block the detrimental effects of ROS have produced mixed or negative results precipitating the interest in antioxidants found in natural products. Blueberries have the highest antioxidant capacity among fruits and vegetables, and had been shown to reduce neurological deficits observed in aged animal models. The objective of this study was to assess the cardioprotective properties of a blueberry enriched diet (BD). Following 3-mo exposure to BD or a regular control diet (CD), the threshold for mitochondrial permeability transition (tMPT) was measured in isolated cardiomyocytes obtained from young male Fischer-344 rats. Compared to CD, BD resulted in a 24% increase (p<0.001) of ROS indexed tMPT. The remaining animals were subjected to a permanent ligation of descending coronary artery. 24 hrs later resulting myocardial infarction (MI) in rats on BD was 24% less than in CD rats (p<0.05). Significantly less TUNEL(+) cardiomyocytes (2% vs 9%) and 40% less inflammation cells were observed in the myocardial area at risk of BD compared to CD rats (p<0.05). In other groups of rats, immediately after coronary ligation, the original diet was either continued or switched to the opposite one, and their cardiac remodeling and MI expansion were followed by serial echocardiography for 10 weeks. Results of echo measurements indicated that rates of post MI cardiac remodeling and MI expansion were proportional to original myocardial damage governed by the previous diet. However, BD or its withdrawal after MI induction, attenuated or accelerated this effect. We concluded that blueberry-enriched diet protected the myocardium from ischemic damage and demonstrated the potential to attenuate the development of post MI chronic heart failure.